Morphology & Image Processing Module

Morphology and Image Processing Module
Abstract
The objective of the Morphology and Image Processing Module is to enhance the capabilities of individual
investigators to conduct cutting edge research in the vision sciences. Our Aims are: 1) to provide resources,
support and training required for conducting morphological studies and image analysis at the level exceeding
the capabilities of any individual laboratory; 2) to promote collegiality across the community of vision scientists
through sharing resources, techniques and expertise; and 3) to engage colleagues into conducting vision
research, including support of the next generation of basic and clinician scientists. To achieve these Aims, this
Module will support sophisticated facilities equipped with state-of-the-art microscopes and other imaging
instruments; microtomes and histology tools; and custom-built software and data processing resources for
image and data analysis. The Module will be supervised and operated by highly experienced personnel, with
expertise in conducting a broad array of tissue preparation, image acquisition, automated data processing and
artificial intelligence methodologies. These shared resources will open new research possibilities for both
experienced and novice users, and will serve as a platform for fostering interactions among a broad swath of
our research community.